Cancer Bioinformatics: Data analysis and method development for the Yale Cancer Center

ABSTRACT
Bioinformatics skills and tools are critical for the analyses of vast amount of data generated by
Next-Generation Sequencing (NGS) and have become an integral field for gaining insight into
cancer biology. While laboratory protocols to generate NGS data have become more
standardized, researchers find it difficult to bring expertise in bioinformatic data analysis into their
practice. The Yale Cancer Center (YCC), one of the 51 NCI-Designated Comprehensive Cancer
Centers in the nation, aims to understand and prevent cancer, detect cancer early, and manage
cancer treatments more accurately and effectively. YCC is committed to fulfilling these goals by
supporting collaborative research and education activities aimed at achieving breakthrough
discoveries and training future leaders in cancer science and medicine. The YCC supports and
manages Shared Resources that provide unique expertise and enabling technologies that enrich
the scope and expedite progress for each of the YCC research programs. As Associate Director
of Bioinformatics at the Yale Center for Genome Analysis (YCGA), one of the YCC Shared
Resources, I established the bioinformatics analysis services for the YCC with the goal of bringing
bioinformatics and NGS expertise closer to the cancer investigators. My bioinformatics work with
them for the last 9 years has focused on three areas: 1) providing full “design-to-publication”
bioinformatics support; 2) facilitating access to new genomic technologies and develop/build new
analytical pipelines to enable cutting edge genomics; and 3) providing training and education in
cancer bioinformatics through mentoring, seminars, and workshops. I have brought such
expertise to over 300 projects for 78 laboratories, have developed new data analysis pipelines
and enabled new NGS applications, and have trained many students and researchers to become
proficient in their own bioinformatics analyses. During my work for the YCC, I have co-authored
over 28 publications in leading scientific journals with YCC investigators, involving a diverse set
of analysis for different techniques, cancer types, and organisms. The support of the R50 award
will allow me to continue to develop and use bioinformatics tools to increase the progress and
scope of cancer research and provide broader access and training to YCC researchers.

Public health relevance
OVERALL PROJECT NARRATIVE Cancer is a genetic disease driven by somatic or inherited mutations and, thus, genomic technologies, particularly next-generation sequencing and bioinformatic analysis, have made significant impact on cancer diagnosis, management, and treatment. However, unlike laboratory protocols and benchwork, researchers find it difficult to bring the necessary expertise in bioinformatic data analysis into their labs. The support of this R50 award will allow Dr. Lopez- Giraldez to provide broader bioinformatics analysis access and training to Yale Cancer Center researchers, and to expedite the progress, enable innovative NGS technologies, and enrich the scope of their research.